TO 23: CLIMATE CHANGE DATA LINKAGES

The purpose of this contract is to support research development activities for NIEHS Epidemiology Branch Investigators focused on the investigation of climate change effects on human health. NIEHS seeks to identify, evaluate, acquire, prepare, validate, and link spatio-temporal data related to climate change, including, but not limited to, built environment, socioeconomic factors, resilience, weather, climate trends and impacts, land cover, and natural disaster events.